Pediatric Acute Kidney Injury Prediction Using Generalized, Sharable, Usable Decision Support

Acute kidney injury (AKI) is a frequent complication among critically ill children and is independently associated
with increased morbidity and mortality. While AKI identification remains largely reactive, early prediction of AKI
provides opportunities for mitigation strategies to improve patient outcomes. Existing pediatric AKI risk
prediction models are primarily driven by single-center data with limited translation into clinical decision support
(CDS) at the point of care. While CDS systems are designed to improve care quality and patient safety, they
have failed to make meaningful improvements while contributing substantially to provider alert fatigue. This is
especially true in pediatric critical care, where alerts and alarms are ubiquitous and often ignored. Disregarding
important alerts may lead to patient harm. The addition of machine learning methods to augment decision
support has been the focus of substantial hype, however clinicians remain skeptical over concerns such as
utility, credibility, and validity. Within this clinical context, this application addresses two specific knowledge
gaps. First, without validated and generalizable prediction tools, the best method for identifying patients at risk
for developing AKI in the pediatric ICU (PICU) is unknown. Second, current CDS systems are burdensome and
there exist no clear recommendations on useful, usable implementations for AKI decision support. The long-
term goal of my research program is to improve the care and outcomes of critically ill children with acute kidney
injury while reducing provider alert frustration through personalized, shareable CDS. As a step toward this
goal, this career development award will demonstrate success of an integrated CDS pipeline for external
validation, cutting-edge technology to facilitate distributed implementation, and usability assessment. The
research aims of this proposal are to: 1) establish baseline external validity of an existing AKI prediction model
and extend with new predictors to improve accuracy within two novel multi-center datasets, each with >80,000
PICU encounters; 2) overcome interoperability barriers using Fast Healthcare Interoperability Resource
(FHIR)-based EHR technology and prospectively evaluate this implementation’s performance; and 3)
implement principles of user-centered design to improve clinician acceptance. With the support of my
mentoring committee, I will gain advanced knowledge and develop expertise in user-centered design,
qualitative methodology, clinical trial design, and implementation science in decision support. This work is
innovative as it leverages two brand-new, highly granular datasets to achieve external validation, implements
an AKI prediction tool using new FHIR-based technology, and utilizes mixed-methods cognitive informatics
tools to perform usability testing. However, the truly innovative aspect of this work is the integration of all three
aims into a single pipeline. This work provides the foundation for a prospective clinical trial evaluating clinical
effectiveness, as well as incorporation of biomarkers and physiologic data streams, and the development of
evaluation measures for decision support systems.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI) occurs frequently in critically ill children and existing decision support tools designed to improve patient care quality and safety have shown limited effectiveness while simultaneously increasing provider alert burden fatigue. This proposal will develop an integrated pipeline to support validated, shareable, usable decision support tools for subsequent clinical trials. Its success will launch a research program focused on improving the care and outcomes of critically ill children with acute kidney injury while reducing provider fatigue.